Administrative Core

PROJECT SUMMARY (See instructions): The Administrative and Assessment Core serves as the central administrative and organizing component of the Program Project. This is a proposal from researchers with significant research administration experience, long-standing collaborative histories, and relevant interdisciplinary and multi-site research management experience. The goal of the Administrative Core is to ensure standardization and consistency in the timely completion of the overall Program Project, including developing and maintaining efficient administrative structures to ensure research, budget, and human subject compliance, effective communication and decision making processes, standardization and oversight of subject selection, development of overall Program Project data management and quality control protocols across all Projects, Cores and sites, and coordination of outside reviews/Project evaluations. In addition, this Core will ensure that other critical aspects of the Project, including test administration protocols, fMRI methodology, treatment implementation and fidelity monitoring, data collection, entry, and transfer, database development, and data analysis processes are all performed using consistent protocols and procedures.

Public health relevance
RELEVANCE (See instructions): Provides coordination between Projects and Cores focused on understanding the neurobiological and neurocognitive foundations of Developmental Dyslexia. Understanding their underlying brain impairments and related neurocognitive disabilities will provide a stronger basis for prevention and improved treatment for these children.